Neuroinformatics for gene expression: networks, function and meta-analysis

Summary
This project helps address challenges neurobiologists face when trying to interpret the results of
genomics and genetics studies, in which a typical aim is to identify candidate genes and
regulatory pathways relevant to normal or disease processes. A common approach is to use
gene network analysis to position findings in a systems biology context. However, identification
of relevant patterns in complex data remains difficult. Our past work resulted in a large database
of expression profiling data, “Gemma” (now over 10,000 studies, including 3,200 relating to the
nervous system) and an extensive series of analyses. This work led to the identification of
specific biases and confounds affecting gene network analysis and gene annotations, and the
development of improved approaches and tools for gene function prediction, gene set
enrichment and cellular composition analysis. Recently we have shown that much of the
variance of expression in brain data sets comes from differences in cellular composition among
samples. Building on this and other work, we propose to extend our research to further the
interpretability of gene expression patterns in the nervous system. Our first aim is to continue
the development of our transcriptomic re-analysis databases, with the expected addition of
approximately 2,500 additional brain-related studies, and an expansion into single-cell
transcriptomics. Our second aim is to assemble and evaluate a high-quality dataset of
transcription factor regulatory targets in brain using a combination of manual curation of the
literature and integration of chromatin immunoprecipitation with transcription factor perturbation
studies along with third-party sources. The third aim brings these topics together to further the
extent to which transcriptomic data can be used to infer changes in regulatory influences in both
single-cell and bulk-tissue data. We hypothesize that our approaches will allow increased
resolution of transcription-factor regulated patterns of co-expression and differential expression.
We will then apply these interpretational tools to re-analyze bulk and single-cell data sets in
neuropsychiatric and neurodevelopmental conditions, and to study candidate genes identified
via genetic association of rare or common variants. All of our data and software will be freely
disseminated via web applications, programmatic interfaces and downloadable data sets.

Public health relevance
Narrative Massive effort has been expended collecting gene expression profiling data in attempts to understand human brain function and disease, but interpreting these data remains a challenge. In this project we build on our investigations in which we re-analyze thousands of published studies to add insights, develop new analytic approaches, and provide databases, tools and data to the neuroscience research community to improve gene expression and gene network analysis. By applying our approaches to disorders of the brain such as schizophrenia and autism, we will increase understanding of the molecular underpinnings of these human conditions.